B-NET Administrative Supplement

Project Summary/Abstract
Declining mobility function is a common age-related phenomenon that is associated with
reduced quality of life and high societal costs. Recently, the brain's critical role in mobility
function has been recognized using imaging approaches assessing white matter characteristics.
A new paradigm considering the brain as acomplex network uses MRI-based approaches to
directly characterize the brain as a functional network. Brain Networks and Mobility Function:
B-NET brings together national leaders in brain network science and mobility assessment to
apply this innovative network paradigm to elucidate the brain's role in declining mobility. We
propose that changes in functional connectivity within and between brain regions supporting
movement predict declining mobility. We hypothesize that age-related structural damage affects
mobility, in part, by degrading the community structure of sensorimotor cortex (SMC) reflected in
lower SMC modularity and increased SMC connectivity to other brain regions.
B-Net established a cohort of 192 community-dwelling older adults (age range 70-85) and
measure mobility function at baseline, 6, 18 and 30 months using the extended short physical
performance battery (eSPPB) to address the following specific aims.

Public health relevance
Project Narrative Brain Networks and Mobility Function: B-NET will apply a new paradigm to understand how aging brain networks affect mobility function to develop novel approaches to prevent age-related mobility decline in older adults.